RANDOMIZED, DOUBLE-BLIND, PLACEBO CONTROLLED TRIAL OF MONTHLY INFUSIONS

Evaluation of the safety and efficacy of monthly infusions of Respigam to prevent RSV infections in premature infants less than six months of age or in infants with BPD less than two years of age.